Homeostatic Stabilization of Neural Function in Health and Disease

ABSTRACT
Homeostatic plasticity (HP) encompasses a suite of compensatory physiological processes that stabilize neural
function. It is widely hypothesized that homeostatic plasticity will be linked to the cause and/or severity of
neurodevelopmental disorders including autism and intellectual disability. Yet, there remains limited molecular,
mechanistic information to directly connect homeostatic plasticity to neurological and neurodevelopmental
disorders. We recently made two significant advances in the field. First, we provide evidence that presynaptic
homeostatic plasticity (PHP) is neuroprotective in mouse models of amyotrophic lateral sclerosis (ALS). This
has given rise to the concept of homeostatic neuroprotection. Second, we have established that PHP is a
potent form of homeostatic plasticity expressed in the adult mouse brain, with a specific focus on hippocampus.
As a consequence, we have now established a pipeline using genome-scale forward genetic screens in
Drosophila to discover fundamental mechanisms of PHP. These mechanisms are then translated to the mouse
neuromuscular junction and adult mouse hippocampal preparations to test conservation of function. If
conserved, we determine the intersection of new homeostatic mechanisms with the pathophysiology of mouse
models of neuromuscular and central degeneration including ALS and FTD. To date, all of the core molecular
mechanisms necessary for PHP, first identified in Drosophila, are conserve in mice, both centrally and
peripherally. We will continue to harness this highly effective strategy to identify the first positive genetic
modulators of PHP, with a goal of promoting homeostatic plasticity and enhancing neurological resilience to
disease. We propose that this will pave a new path toward therapeutic development based on the rational
manipulation of homeostatic plasticity.

Public health relevance
Project Narrative Homeostatic plasticity stabilizes neural function throughout the lifespan. We will establish how failure of homeostatic plasticity contributes to the pathophysiology neurological diseases of the neuromuscular system and central brain. We will also determine whether potentiation of homeostatic plasticity is a new neuroprotective strategy to combat the onset and progression of neurological disease.